Structural basis for activity of and resistance to HIV integrase inhibitors

ABSTRACT
The Human Immunodeficiency Virus Type 1 (HIV-1, hereafter referred to as HIV) currently infects ~40 million
people worldwide, and the number of infected individuals continues to rise. In the absence of a cure, antiretroviral
therapy represents the primary treatment option, because it slows disease progression and reduces new
infections. Integrase (IN) Strand Transfer Inhibitors (INSTIs) are a class of antiretroviral therapeutics that block
integration of viral DNA into host chromosomes, a process that is mediated by the viral IN enzyme, which
assembles into oligomeric nucleoprotein complexes on the ends of viral DNA, termed “intasomes”. INSTIs
selectively target intasomes and represent first-line therapies in the clinic. However, the emergence of IN variants
resistant to INSTIs is becoming a greater clinical problem. Structural biology approaches can shed light on the
mechanisms underlying drug action and resistance, providing useful information for rationally improving the
current INSTIs. When complemented with ancillary techniques, such as biochemical activity assays, biophysical
thermodynamic and kinetic measurements, cellular virology, and diverse computational approaches including
free energy calculations, the structures precisely detail mechanisms of resistance against specific INSTIs and
provide guidance for designing and developing novel 3rd generation INSTIs to fight infections. In this proposal,
approaches centered around using revolutionary advances in cryo-electron microscopy for structural studies will
show how INSTIs interact with their natural drug target, the HIV intasome (both WT and mutant), and elucidate
the mechanisms by which resistance to these drugs emerges. There are three Specific Aims that will: (1) extend
and build upon current efforts to provide a mechanistic understanding of both why and how select viral resistant
variants (VRVs) arise in response to the clinically used drug Dolutegravir (DTG) or the most potent
developmental in-house compound that 4d, which is currently under pre-clinical evaluation; (2) broadly identify
and analyze novel mechanisms and pathways of drug resistance that arise in response to treatment with 2nd
generation drugs, highlighting both primary and compensatory mutations, and providing strategies to predict
future variants; (3) select for residual resistant variants arising in response to treatment with novel 3rd generation
INSTIs that were synthesized based on the concept of substrate mimicry, many of which effectively inhibit viral
resistant variants that arise in response to treatment with 2nd generation clinically used INSTI drugs, and explain
mechanisms underlying the superior potency of novel compounds. This work will improve our understanding of
an important class of drugs used to treat people living with HIV, identify mechanisms, pathways, and patterns of
clinically relevant resistance to INSTIs, and provide specific guidelines for their rational improvement.

Public health relevance
PUBLIC HEALTH RELEVANCE Integrase (IN) Strand Transfer Inhibitors (INSTIs) are first-line therapeutics used to treat people living with HIV/AIDS, which work by blocking integration of viral DNA into host chromosomes through inhibition of the HIV intasome nucleoprotein assembly, but the emergence of IN variants resistant to INSTIs is becoming a greater clinical problem. This work will make use of structural biology and complementary enzymological, biophysical, virological, and computational approaches to define mechanisms of HIV drug resistance against the latest clinically used INSTIs, identify and characterize patterns and pathways through which clinically relevant resistance arises, synthesize potent third generation INSTIs based on the concept of substrate mimicry, and use our collective tools to mechanistically explain drug potency against viral resistant variants. The results of this work will improve our understanding of this important class of drugs used to treat people living with HIV, identify mechanisms, pathways, and patterns of clinically relevant resistance to INSTIs, and suggest specific guidelines for their rational improvement, thus providing realistic strategies for combatting drug resistance to HIV.